CBHATTC 2nd National Conference on the Hispanic Family

DESCRIPTION (provided by applicant): The Universidad Central del Caribe (UCC), through its Center for Addiction Studies and the Caribbean Basin and Hispanic Addiction Technology Transfer Center (CBHATTC), is requesting support to implement "The Second National Conference on the Hispanic/Latino Family: The Role of the Hispanic/Latino Family as a System of Drug Use Treatment and Prevention," to be held August 18-20, 2004 at the San Juan Marriott in San Juan, Puerto Rico. The Conference is part of the Center for Addiction Studies and CBHATTC's educational commitment to continually pursue the goal of "Blending Research/Science to Practice." The conference is designed both to build a knowledge base among participants regarding up-to-date research findings in each of the themes of the conference to provide an environment in which Hispanic drug treatment providers, others who serve Hispanic populations, and researchers can interact and develop relationships and coalitions that may result in conjoint research endeavors. The conference program is structured around the subtheme of "From molecules/genes to community to culture," and is comprised of pre-conference workshops, plenary sessions, workshops, and poster sessions. Major topics to be covered include the neuroscience of addiction; family-centered approaches to prevention and treatment of substance use; community and cultural factors which may facilitate or impede the family's ability to address substance use among its members; and issues of trauma and violence, sexual identity, and co-occurring disorders as they relate to substance abuse and its treatment and prevention. A Conference Proceedings document is to be developed in Spanish and English, which will be available to all states through the SAMHSA/CSAT ATTC Network and the NIDA National Hispanic Science Network. The conference approach is guided by elements of Hispanic culture, and the theories of Diffusion of Innovation and Successful Technology Implementation.